Confocal and Specialized Microscopy Shared Resource

CONFOCAL AND SPECIALIZED MICROSCOPY SHARED RESOURCE: PROJECT SUMMARY
The Confocal and Specialized Microscopy Shared Resource (CSMSR), directed by Liza Pon, PhD, provides
access to advanced imaging technologies for Herbert Irving Comprehensive Cancer Center (HICCC)
members. Imaging services include: (1) scanning confocal microscopy (including resonant scanning and
spectral imaging), (2) two-photon and second-harmonic generation microscopy, (3) spinning-disk confocal
microscopy, (4) super-resolution microscopy (Structured Illumination and Stochastic Optical Reconstruction),
(5) wide-field fluorescence and color histology imaging, (6) micro-irradiation and laser capture
microdissection, and (7) support for image processing, visualization, and quantitative analysis. These
comprehensive and integrated services and technologies facilitate analyses of living and fixed cells and
tissues in a broad range of cancer models used by HICCC members. During the current reporting period, this
state-of-the-art facility updated much of its equipment and incorporated new instruments with support from
the HICCC and shared instrumentation grants. This includes acquisition of a cell imaging and multi-mode
microplate reader and a multiplate long-term live cell imaging system, as well as major upgrades in Spectral,
Resonant-Scanning One- and Two-Photon Confocal and 3D structured illumination super-resolution/scanning
confocal microscopes. As result, the CSMSR has expanded its capacity and portfolio of services. In
combination with its advanced equipment, highly qualified staff, a broad portfolio of specialized services, easy
accessibility, and high cost-effectiveness, the CSMSR is the service provider of choice for HICCC members
for advanced imaging. In annual user surveys, the CSMSR is consistently ranked as one of the most highly
valued resources at the HICCC. The CSMSR provides services that are not available from commercial
sources and not easily accessible at other sites and that are of central importance to the research of numerous
HICCC members. In addition to providing both basic and advanced services across different microscopy and
imaging platforms, the CSMSR also provides training to HICCC members in the operation of imaging
instruments and in image data visualization and analysis. In addition, consulting services in experimental
design by expert personnel in the CSMSR facilitate incorporation of advanced imaging techniques into the
research portfolio of HICCC members. The CSMSR will continue to incorporate novel imaging platforms and
technologies, to provide state-of-the-art imaging services, and to promote high value and accessibility through
training and consulting with the goal of empowering the research programs at the HICCC. Over the current
project period (2014-2019), the capabilities of the CSMSR were utilized by 66 HICCC members, supported
key data and insights facilitating 61 HICCC Member peer-reviewed publications, including 30 contributions in
journals of the highest impact factor (IF>10), of which 16 were in journals with and impact factor >20 (e.g.,
Cell, Nature, Cancer Cell), and currently supports research 44 NIH funded research project grants (25 NCI).